Trinucleotide Repeats: Atypical Structures, Diseases, and Evolution

? DESCRIPTION (provided by applicant): This proposal brings together a small focused group of four researchers to investigate fundamental biological questions associated with trinucleotide repeats (TRs). TRs are the most common type of simple sequence repeats found in the exome of all known eukaryotic genomes. They are associated with high mutation rates of the repeat number, which leads to frequent polymorphism in the coding regions of the genes with a rapid expansion of the amino acid repeats. TRs display dynamic mutations that do not follow Mendelian inheritance. One eﬀect of this results is to give rise to a series of genetic diseases for which the age of disease onset and its severity increases with successive generations. The mutations responsible for these diseases are associated with intergenerational expansion of the TR. Once the repeated length of the TR reaches a certain threshold, the probability of further expansion and severity of the disease increases with the repeat length. TRs in human genes can cause severe neurodegenerative and neuromuscular disorders that lead to cell toxicity and ultimately death. While the mechanisms underlying these diseases are complex, some fundamental aspects have been recognized, such as the correlation between the repeat length and probability of further expansion and the increased pathological severity. It as also been recognized that the critical step in these diseases involves the transient formation of atypical non-B DNA stable secondary structures in the expandable repeats. The goal of this proposal is therefore to address the characterization of these atypical structures from three diﬀerent angles. Speciﬁcally, we will use large-scale atomistic simulations to address issues with regards to the conformations, relative stability, dynamics, and repeat-length dependence of atypical TR secondary structures such as slip-stranded duplexes, single-stranded hairpins, Z-DNA, DNA triplexes, etc. Second, single molecule ﬂuorescence resonance energy transfer (smFRET) experiments will be used to characterize the kinetics and free energies of DNA hairpin transitions. This will provide important experimental input and validation for the computational eﬀorts in elucidating the properties of atypical TR structures. Finally, we will use statistical genetics approaches to incorporate the role of TRs in genome evolution. By coupling data on genetic variation to our molecular dynamic simulations, we will characterize the relationship between evolutionary rates and propensity of the TRs to form atypical secondary structures. We will investigate the origin of genetic variation (mutation), intraspeciﬁc genetic variation (polymorphism), and inter- speciﬁc genetic divergence. Illuminating the link between atypical TR structures and parent-oﬀspring mutation data will be a much needed preliminary step toward a mechanistic understanding of the TR mutation process.

Public health relevance
PUBLIC HEALTH RELEVANCE: Trinucleotide Repeat (TR) Disorders (Huntington's disease, ataxias, myotonic dystrophy, etc) are caused by an expansion of TRs in certain genes, such that after a threshold typical of each disease, the expansion leads to cell toxicity and death. We will elucidate the atypical TR structures and their role in evolution, with the goal of controling the pathological expansions.